Mechanistic and neuroanatomic bases of disparity between arm capacity and use in stroke

Project Summary
More than 750,000 individuals in the U.S. have a stroke each year, and as many as 94% of stroke survivors
exhibit reduced use of one arm, with adverse consequences for disability, caregiver burden, and quality of life.
Approximately 40%-80% of individuals who fail to use the affected arm in daily life possess adequate sensory-
motor capacity to do so. The disparity between arm use and capacity (i.e., Use/Capacity Disparity -- UCD)
occurs across a broad spectrum of sensory-motor severity and is a perplexing and urgent problem in neuro-
rehabilitation. Perhaps in part because UCD lies at the interface of sensory-motor processing and
cognitive/affective phenomena, no past research has assessed its underlying mechanisms or neuroanatomic
biomarkers. Given its prevalence, an understanding of the mechanisms of UCD across a range of severity is
required to develop targeted treatments to ameliorate the disorder. Moreover, individuals with stroke are
rarely assessed for the presence of UCD, in part because such assessment is challenging. The proposed research
will address these gaps in our knowledge and capacity by testing the predictions of 3 hypotheses of the
mechanisms underlying UCD: the sensorimotor, attention, and apathy/motivation accounts. In Aim 1 we will
administer a targeted battery of sensorimotor and neuropsychological tests to test the predictions of each of the
3 hypotheses in a sample of 100 mild to moderate left- and right-hemisphere chronic stroke patients. We will
determine the association of these measures as well as demographic and stroke-related variables with UCD.
Aim 2 will use advanced neuroimaging methods with data from resting-state functional magnetic resonance
imaging to develop imaging biomarkers associated with UCD. In Aim 3 we will validate a novel virtual reality
assessment tool to rapidly and reliably evaluate UCD. In addition to its clinical utility, the task enables built-in
assessment of the attention hypothesis by determining whether UCD is influenced by attentional task
demands. By the end of the grant period, we will have determined the demographic, sensorimotor,
neuropsychological, and neuroanatomical factors that predict UCD and validated a clinically-useful VR
assessment tool. Given the limited knowledge base in this area, this comprehensive research will pave the way
for development of treatments targeted to underlying mechanisms and enhanced identification of at-risk
individuals.

Public health relevance
More than 750,000 individuals in the U.S. have a stroke each year, and as many as 94% of stroke survivors exhibit reduced use of one arm, with adverse consequences for disability, caregiver burden, and quality of life. Approximately 40%-80% of individuals who fail to use the affected arm in daily life possess adequate sensorimotor capacity to do so. The disparity between actual arm use and capacity remains a perplexing and urgent problem in neuro-rehabilitation. The proposed research will determine the underlying behavioral and neuroanatomic substrates of arm use/capacity disparity (UCD) and will validate a novel virtual reality assessment tool for detection of UCD. The investigations are designed to serve as a well-planned stage in the translational pipeline and will thus provide a critical bridge to developing a large-scale randomized control trial in at-risk individuals using a targeted treatment.